Omics Data Integration to Identify Disease Pathways in COPD

Project Summary Although chronic obstructive pulmonary disease (COPD) occurs predominantly in smokers, it is unknown why only a minority of smokers (~20-40%) develops chronic airflow limitation and/or destruction of distal airspaces (emphysema). Using several NIH and foundation grants, we have systematically generated genetic, genomics, proteomic, and metabolomics profiles from the NHLBI supported COPDGene cohort, which includes 10,300 current and former smokers age 45-80. This proposal will focus on integrating the omics data generated in the five-year followup (Phase II) of the COPDgene study to identify molecular subtypes of COPD across a broad range of blood profiles (Specific Aim 1). Biomarkers and pathways discriminating the molecular subtypes, in addition to other COPD phenotypes will then be identified (Specific Aim 2). These results will identify markers that are specific to smoking-related lung disease and can be used to develop novel diagnostic tests and therapies for early prevention and treatment of COPD.

Public health relevance
Relevance to Public Health Chronic obstructive pulmonary disease (COPD) is the third most common cause of death in the United States. The major risk factor is smoking; however, most smokers do not develop COPD and the factors that identify who goes from normal to abnormal lung function are unknown. This proposal will use already collected data on existing NHLBI cohorts to identify blood signatures that can identify who will be at risk for developing smoking related lung disease. The knowledge gained will help guide treatment strategies and improve prognosis assessments.